2025 RNA Editing Gordon Research Conference and Gordon Research Seminar

Project Summary
The GRC on RNA Editing is the most important international meeting addressing the modifications that alter the
4 standard nucleosides found within RNA and their implications in health and disease. Today, we realize that
RNA editing and modifications play fundamental roles in translation, gene expression, innate and adaptive
immunity, cognition, neurological disorders, cell differentiation, and cancer. Furthermore, population-wide human
genome data has associated polymorphisms in modification enzymes, and their RNA targets, with varied
disorders, providing crucial genetic links. Importantly, paths have been forged between basic science and
industry by repurposing RNA editing and modification systems as therapeutics. In these efforts, investigators
associated with the GRC are paving the way by founding a series of biotechnology companies based wholly or
partly on these technologies. Accordingly, the GRC on RNA Editing is an impactful event where international
leaders in the field meet with promising early career principal investigators and trainees to share data and ideas
in order to nucleate the next generation of consequential discoveries. To support these overarching goals, the
2025 GRC on RNA Editing will focus on the following specific aims. First, this event will help develop the next
generation of scientific leaders that will drive the field of RNA editing and modifications forward. To support this
aim, the GRC will be preceded by a 2-day GRS, focused entirely on trainees and their mentorship. Moreover,
the RNA Editing GRC will strategically ensure that our community is diverse, equitable and inclusive by
supporting trainees and early career scientists, women, and underrepresented scientists, and by offering a
“power hour” focused on promoting diversity and inclusion and career development. Second, the meeting will
stimulate the exchange of transformative ideas in the area of RNA editing and modifications in order to nucleate
novel, interdisciplinary discoveries. This aim is facilitated by the unique GRC format which, besides the talks,
sponsors forums, and provides generous free time to promote networking. During the 5-day GRC itself, 51 talks
and 2 keynote addresses will be spread out over 9 thematically diverse sessions with strong ties to many human
diseases. Third, this GRC will facilitate the translation of academic discoveries in the area of RNA editing and
modification into health-related industrial applications. Towards this aim, we will include many representatives
from RNA editing and modifications companies, who will give talks and participate in mentorship sessions. One
entire session will be dedicated to novel therapeutic applications of RNA editing systems. In conclusion, the 2025
GRC on RNA Editing will accelerate discovery and application of RNA editing and modification by inspiring
research into biological mechanisms, by fostering knowledge translation, by building a strong, diverse, and
inclusive community and by developing the next generation of creative scientists. Thereby, it will ultimately
promote broad research initiatives, biotechnological and economical advancements, and improvements to
human health.

Public health relevance
Project Narrative The 2025 GRC on RNA Editing is the premier international meeting dedicated to modifications within RNAs and their biological consequences and implications in human health. RNA editing and modification is critical for autoimmune diseases, viral and microbial infections, behavioral and intellectual disorders, cancer and many inherited diseases, and recently new therapeutic strategies are being developed using targeted RNA editing and modified mRNA vaccines. Accordingly, the GRC on RNA Editing is particularly consequential because of its track record of connecting basic science to human health and industry.